Mechanisms underlying impaired diabetic wound healing

ABSTRACT Persistent unresolved inflammation impairs diabetic wound healing. The function and fate of wound monocyte/macrophages hold the key to the outcome of wound inflammation. This proposal builds on observations originating from live functional wound macrophages (wmφ) and wound fluid (WF) derived from chronic wounds of patients which were then developed further using experimental models. Given current ambiguity in macrophage nomenclature, and proposed misfit of wmφ with the M1/M2 nomenclature, for this proposal we classify ?mφ based on the pro-inflammatory (mφinf) or pro-resolution/healing (mφheal) functional states. During the last cycle, we reported that i) successful wmφ efferocytosis (Eff) helps resolve inflammation; and ii) that efferocytosis was severely impaired (Efflo) in wmφ of diabetic wounds causing unresolved inflammation. Recently, our laboratory was the first to report a critical role of miRNA-21 in the regulation of wound inflammation. The proposed study recognizes (i) ?mφ efferocytosis functional status, and (ii) ?mφ miR- 21 as two critical factors required for advancing pro-inflammatory wmφ (mφinf) to mφheal. wmφ are attractive therapeutic target for improved wound healing outcomes. Importantly, through nanoparticle based mφ targeted delivery of miR-21, and rMFG-E8 application, both factors may be modified with therapeutic intent. Another seminal observation is the detection of FSP1+Collagen1A1 producing fibroblast-like cells (mφF) of myeloid origin at wound-site. This raises the question, do plastic wmφ transition to fibroblast-like cells at the wound site? We hypothesize that in the wound microenvironment, efferocytosis and miR-21 are critical determinants of wmφ reprograming of mφinf→mφheal or mφinf→mφF functional states. Diabetic wmφ suffer from Efflo and miR- 21lo. This combination stalls wmφ in mφinf resulting in chronic inflammation. The following 3 aims are thus proposed: Aim 1: Test efferocytosis and miR-21 as critical determinants of wound monocyte/macrophage (wmφ) fate. §1.1 A subset of wmφ undergoes mφinf→mφheal; §1.2 Another unique subset of wmφ undergoes mφinf→mφF. Aim 2: Determine how diabetes redirects the fate of wmφ resulting in derailment of healing. §2.1 Diabetic wmφ suffer from two critical impairments, impaired efferocytosis (Efflo) and low miR-21 (miR-21lo), the combination of which stalls wmφ in mφinf; §2.2 Targeted nanoparticle delivery of miR-21 to diabetic wmφ advances some such cells primarily to mφF; §2.3 In diabetic wmφ, correction of miR-21 (§2.2) in combination with correction of efferocytosis resumes physiological healing advancing diabetic mφinf→mφheal/mφF. Aim 3: Study live wmφ and wound-edge tissue biopsies isolated from wounds of diabetic patients testing whether §3.1 wmφ transition to mφF; §3.2 correction of miR-21 and efferocytosis advances diabetic wmφ to mφinf→mφheal/mφF .

Public health relevance
Project Narrative In the United States, skin wounds affect 6.5 million patients placing a major burden, estimated at US $25 billion annually, on society. Persistent inflammation in wound tissue is a major contributor to wound chronicity, specifically in diabetic ulcers. The proposed project aims to identify novel pathways that regulate the function and fate of wound monocyte/macrophages. These cells are major regulators of wound inflammation. Successful completion of the project will offer critical new knowledge that is clinically relevant and aims at improving management of diabetic wound inflammation.